Multidisciplinary Training in Translational Gastrinointestinal and Liver Research

Project Summary
This is a renewal application from the Columbia University's Vagelos College of Physicians and Surgeons for
its postdoctoral training program in digestive and liver diseases. The program's mission is to train MD and
MD/PhD trainees to become independent basic, clinical and translational researchers in gastroenterology and
hepatology. The program has been in existence for nine years to date and has been highly successful in this
mission. Trainees are selected from gastroenterology fellows in the Department of Medicine and Department of
Pediatrics at Columbia. The gastroenterology fellowship programs in both Medicine and Pediatrics are diverse,
highly competitive and put a primary emphasis on research training in both the selection and training of their
fellows. This provides for an exceptionally strong pool of applicants to the training program. Furthermore, the
training programs has succeeded in and will continue to recruit outstanding trainees from underrepresented
minority groups. The program faculty is multidisciplinary and includes mentors not only in the Department of
Medicine and Department of Pediatrics but also in other departments, institutes and centers at Columbia
University. Most of the mentors are well-established, NIH-funded investigators but several early-stage junior
mentors, who are paired with established mentors for training purposes, are also included. Trainees chose to
pursue research in three broad thematic areas – 1) basic gastroenterology research, 2) basic liver research
and 3) clinical epidemiology/precision medicine – and select a mentor in one of these areas. Trainees devote
most of their effort to a mentored research project but also complete a rigorous program of didactic instruction,
including, if they chose, the opportunity to obtain a master's degree in clinical research. In addition, strong
emphasis is given to training in the responsible conduct of research and in rigor and reproducibility. Dr.
Timothy C. Wang serves as Director of this training program and is ably assisted by Associate Directors Drs.
Joel Lavine and Howard Worman. Each of these individuals have productive, active research programs and
superb track records in postdoctoral training and medical education. The program is supported by both an
Internal Advisory Committee of institutional leaders at Columbia and an External Advisory Committee of
leading researchers in gastroenterology and hepatology at other institutions. The training program leverages
other NIH-funded entities at Columbia University, including its Clinical and Translational Science Award
program and educational programs within it. This training program will continue to produce exceptional
physician-investigators in basic and clinical research in gastroenterology and liver diseases who will make
significant contributions to our nation's public health.

Public health relevance
Project Summary This training program addresses our need for more researchers in digestive and liver disease. Approximately 65 million Americans are affected by such diseases and more well-trained researchers are needed to advance our knowledge of digestive disease pathogenesis, prevention and treatment to better our public health.